Clinical significance and genetic determinants of novel imaging measures of emphysema distribution in 9,743 smokers

PROJECT SUMMARY/ABSTRACT
Candidate: Dr. Adel El Boueiz is a pulmonary and critical care physician-scientist completing a period of T32-
funded support at the Channing Division of Network Medicine (CDNM) and Harvard Medical School (HMS). He
received a Master's of Medical Science in Biomedical Informatics from HMS in May 2016. He will be promoted
to Instructor of Medicine at the CDNM and HMS on July 1, 2017. His principal research interests are the
genetic epidemiology of chronic obstructive pulmonary disease (COPD) and the translation of genomic
discoveries into clinical practice and public health. His long-term goal is to be an independent investigator with
expertise in imaging phenotyping, genomics, and predictive analytics of the regional heterogeneity of the
various aspects of COPD (emphysema, airway disease, and pulmonary vascular remodeling).
Environment: Dr. El Boueiz will continue to pursue his research and career development in the rich and
multidisciplinary environment of the CDNM and the Brigham and Women's Hospital Applied Chest Imaging Lab
(ACIL). He will be mentored by Drs. Edwin K. Silverman, Peter J. Castaldi, and Raúl San José Estépar,
leaders in the field of COPD quantitative imaging, genetic epidemiology, and predictive analytics with excellent
track records of mentoring young investigators towards independent research careers. His career development
will also be overseen by an advisory committee with expertise related to key areas of his proposal.
Research: COPD is a major cause of morbidity and mortality that is of increasing public health importance.
COPD is a heterogeneous disease and this heterogeneity complicates the identification of the predictors of
disease progression and consequently, the development of effective therapies. Emphysema distribution is an
important COPD-related phenotype that emerged as a strong predictor of the response to lung volume
reduction procedures. Despite the availability of advanced texture-based CT quantification methods, global
threshold-based quantitative metrics have to date been the cornerstone for the radiological characterization of
emphysema distribution with inability to differentiate centrilobular, panlobular, and paraseptal emphysema
patterns. In this project, we will apply a texture-based CT quantification method to discover novel imaging
biomarkers of the regional heterogeneity of centrilobular, panlobular, and paraseptal emphysema in a large
cohort of well-characterized smokers and identify their genetic determinants using whole genome sequencing
and integrative genomics analyses. The results will be considered for inclusion along with other rich phenotypic
and imaging data in COPD disease progression machine learning predictive models.
Relevance: Through improved radiographic phenotyping of emphysema distribution, better understanding of
disease pathobiology, and more accurate prediction of disease progression, the proposed work will open new
avenues of investigation for the development of personalized and improved COPD therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) is a common disease that affects up to 24 million people in the United States, is associated with considerable and increasing morbidity and mortality, and for which there is no available disease-modifying therapy. COPD is associated with significant variation in radiographic, symptomatic and physiologic presentation and exhibits variability in progression. Currently, there is no satisfactory method for progression prediction. This project will identify novel imaging biomarkers of the regional distribution of centrilobular, panlobular, and paraseptal emphysema with particular emphasis on their associations with clinical relevant COPD-related outcomes, their genetic determinants, and their ability to improve prediction of COPD disease progression, above and beyond that provided by the traditional clinical, radiographic, and genetic features. This is an important area of research as predicting those patients who will remain stable from those who will have rapid disease progression is critical in defining prognosis and selecting patients for specific therapeutic interventions.